National Resource for Advanced NMR Technology

A major part of the scientific program of the parent project (1RM1GM148766) is based on one of
the most successful Magic Angle Spinning Dynamic Nuclear Polarization (MAS-DNP)
instruments worldwide. This cutting-edge instrument continues to drive breakthrough
discoveries in the studies of a wide array of biological systems, chemical compounds, and
advanced materials.
The instrument consists of five critical components: an NMR console, NMR probes, a
microwave source, cooling cabinet, and an NMR magnet. Crucially, this instrument requires a
continuous supply of cold nitrogen gas to operate at its nominal temperature of ~100 K. The
generation of cold gas is enabled by a sophisticated heat-exchanger and temperature-flow
regulation system (hereafter "cooling-cabinet") that has been in operation for approximately 10
years and is now reaching the end of its functional lifespan.
To provide optimal support and maintain the instrument's world-class capabilities, we have
proactively upgraded multiple components: we have leveraged institutional funding to replace
the NMR console and the microwave source, while the parent project funds development of
advanced probe technology. The current cooling cabinet, however, is no longer supported by
Bruker and is incompatible with the new console, creating an urgent technical bottleneck that
threatens the continued operation of the entire system.
The acquisition of a new cooling cabinet is not merely beneficial but essential to maintain the
productivity of this instrument and ensure seamless integration with the modern console.
Without this critical upgrade, the instrument's reliability and performance will inevitably degrade,
jeopardizing ongoing research projects for dozens of users and greatly reducing our ability to
accomplish many of the specific aims of the parent proposal. This targeted investment will
secure another decade of reliable operation for this high-demand research platform that serves
20-30 unique users annually.

Public health relevance
NMR spectroscopy uses strong magnets and radio frequency technology in the study of metabolomics and the structural biology of proteins, membrane proteins and complexes they form, providing powerful means for understanding how structure, dynamics, and chemistry drive functional mechanisms. We propose to purchase new equipment essential to maintaining and improving the operation of one of the most successful and productive Dynamic Nuclear Polarization instruments worldwide. The improved facility will be available for biologists, biomedical engineers and all scientists with projects that require its unique capabilities.